HEAL - TO SUPPORT THE NIMH NDA WHICH IS A SINGLE DATA INFRASTRUCTURE WITH SINGLE PROCESS FOR CONTRIBUTING DATA AND GAINING ACCESS TO SHARED DATA. CURRENT KEY

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.